Strengthening Healthcare and Research Engagement through Data Sharing: SHARE

Project Summary/Abstract
Coronary artery bypass surgery (CABG) is associated with stroke
, cognitive decline, and dementia. Up to 25%
of patients show signs of brain emboli after CABG, and even minor strokes can reveal hidden brain damage and
worsen cognitive decline post-surgery. This bioethics supplement focuses on neurohealth data sharing and is
nested within the parent grant (R01NS123639). While data sharing practices are rapidly evolving, there is a gap
in understanding perspectives of the public, research participants, and stakeholders regarding these practices
and how these perspectives may deter research participation. The objective of Strengthening Healthcare and
Research Engagement through Data Sharing (SHARE) is to evaluate the perspectives of diverse members
of the public, research participants, and the clinical research community regarding current data sharing practices
in neurohealth research to create more inclusive, patient informed comprehensive data-sharing practices. The
overall objective of the proposed bioethics supplement is to explore timely neuroethical questions to evaluate
diverse perspectives, specifically from underrepresented racial and ethnic minority groups, to foster more
inclusive, patient-informed comprehensive data sharing practices. We expect that results from this supplement
will impact bioethics-related policy and capacity-building in the field while providing an evidence base for future
policy directions. Guided by strong preliminary data, we will conduct two specific aims: 1) evaluate perspectives
of multiple stakeholders participating in the ROMA:Cognition study related to priorities and concerns about
neurohealth data access and sharing, and 2) evaluate public perspectives in the United States on comprehensive
data sharing of neurohealth research data. This research is significant because it will provide new insight into
public perspectives on comprehensive data sharing and ways that researchers can build trust in research.
SHARE is aligned with NINDS priorities for neuroscience research, specifically returning research results to
participants, informed consent-related issues on data sharing, collecting, and sharing neurohealth data. This
supplement will increase the likelihood of impacting bioethics-related policy and capacity building in the field,
provide an evidence-base for future policy directions, and address timely bioethical concerns related to data
sharing from underrepresented racial and ethnic minority groups.

Public health relevance
Project Narrative The proposed supplement will provide insights into the development of patient centered, ethical standards for data-sharing through evaluation of data sharing preferences and governance for disseminating that data with external recipients. This program of bioethics research will also inform bioethics-related policy through providing an evidence base for future directions. The proposed research is relevant to the NINDS’s mission to investigate neuroethical questions to improve neurological health for all people, especially those experiencing health disparities and populations underrepresented in science.